Research Education Core

PROJECT SUMMARY
Research Education Core
TU FCCC: Carolyn Fang, PhD (Core Leader) HC: Charles M. Drain, PhD (Core Leader)
The TUFCCC/HC Cancer Partnership provides a multidisciplinary environment rich in research, education, and
training opportunities and professional mentorship. The proposed Core capitalizes on the numerous strengths
in training and research education across Temple University Fox Chase Cancer Center (TUFCCC) and Hunter
College (HC) to facilitate the professional enrichment of students and junior investigators underrepresented in
cancer research. In addition to research training, the Research Education Core will nurture and mentor
students throughout their studies, infuse 21st century skills of collaboration and communication, and develop
professional career opportunities. The overarching goal of the Research Education Core is to support
educational activities that complement and enhance the training of a diverse workforce to meet the nation's
cancer research needs. To achieve this goal, the Research Education Core will address the following specific
aims: Aim 1. The TUFCCC/HC Cancer Partnership will develop and implement a comprehensive cancer
research education program that provides research enrichment opportunities for 6 junior/senior-level URM
undergraduate and 4 first-year URM graduate students per year (total of 50 URM students over 5 years).
Specifically, the Core will offer unique opportunities including a 10-week intensive Summer Cancer Research
Institute (SCRI) for undergraduate and graduate students in biomedical, clinical, or population-based cancer
research; ongoing skills-based training through mentored research projects; and a rich curriculum of cancer
seminars, workshops, journal clubs, and grand rounds throughout the academic year. Aim 2. The
TUFCCC/HC Cancer Partnership will provide mentorship and research support for 5 URM cancer fellows
(postdocs, junior faculty, or early-stage investigator) to enhance career development and facilitate their
transition to independent investigators. The Core will offer an established environment to support the career
development of at least 5 cancer fellows, who will receive close mentorship and support for two years, through
the implementation of mentored research projects supported by pilot project funds. Aim 3. The TUFCCC/HC
Cancer Partnership will facilitate academic-community research opportunities to support the conduct of
culturally appropriate cancer research in partnership with underserved minority communities and populations.
The Core will increase access to educational and research opportunities that utilize multidisciplinary
approaches and engage underserved minority communities in addressing cancer health disparity research
questions through collaborative academic-community partnerships. In sum, the proposed Research Education
Core represents an exceptional opportunity to capitalize on the unique resources and well-established
collaborations among TU-FCCC, Hunter College, and numerous community-based organizations located along
the New York-Pennsylvania corridor, to facilitate and promote research education and training of students and
junior investigators who are underrepresented in cancer research.

Public health relevance
PROJECT NARRATIVE Research Education Core The overarching goal of the Research Education Core is to support educational activities that enhance the training of a diverse workforce to meet the nation's cancer research needs. The Core will bring to bear a broad range of resources across Temple University Fox Chase Cancer Center (TUFCCC) and Hunter College (HC) to facilitate productive and sustained partnerships that will enhance the academic and research performance of students, postdoctoral fellows, and junior investigators from underrepresented minority populations. As a result, the Core will make a significant contribution toward the goal of recruiting, nurturing, and preparing highly trained cancer researchers from racial/ethnic minority, disadvantaged, and other underrepresented groups.